Cardiovascular Impact of Near-complete Estrogen Deprivation for Breast Cancer

Abrupt menopause induction together with anti-estrogen therapy improves recurrence-free
survival in breast cancer and is a new standard of care for premenopausal women with hormone
receptor (HR)-positive breast cancer. This near-complete estrogen deprivation (NCED) therapy
also places these women at risk of organ compromise associated with early hypoestrogenemia.
Early hypoestrogenemia in women with non-cancerous reasons for premature menopause is
associated with significant cardiovascular (CV) compromise including atherosclerosis and
coronary artery disease, which can be detected preclinically by myocardial perfusion imaging and
computed tomography angiography. Less is known about how NCED therapy will impact CV
health in the tens of thousands of premenopausal women diagnosed with HR-positive breast
cancer each year who will see NCED therapy. It is critical to understand the early natural history
of this risk because clinical CV disease related to hypoestrogenemia will not be reversible. Given
the prevalence of HR-positive breast cancer and marked improvements in survival following
breast cancer, long-term CV sequalae from cancer treatments have the potential to both impact
large numbers of women and offset these survival gains. We will study the early impact of NCED
on the CV system to identify pre-clinical markers of myocardial compromise. The CV health of
women initiating NCED will be assessed by comprehensive, quantitative serial cardiac magnetic
resonance imaging stress studies over a two-year period to document changes in flow of both
small and large CV vessels as well as overall left ventricular structure and function.
We will test the overarching hypothesis that premenopausal women receiving NCED for HR-
positive breast cancer have CV declines that can be identified preclinically using the following
aims: Characterize and quantify the extent of microvascular injury and perfusion changes
experienced during early NCED therapy; Characterize and quantify the extent structural and
functional alterations to the aorta and left ventricle while on NCED therapy; Identify potential
biomarkers and additional risk factors for CV decline in patients receiving NCED. The knowledge
derived from these aims will provide an understanding of which patients are at risk of CV
compromise from NCED. These studies will further enable development of standard of care
predictive tools to assess CV decline in women on NCED before it is clinically apparent with the
goal of allowing women to safely remain on anti-neoplastic regimens and thereby lower both the
burdens of cancer and cardiovascular treatment-related toxicity.

Public health relevance
Narrative New treatment recommendations for premenopausal women with high or intermediate risk hormone receptor breast cancer now include ovarian function suppression, to induce early menopause combined with anti-estrogen therapy resulting in near-complete estrogen deprivation. This abrupt menopause induction together with anti-estrogen therapy improves survival from cancer yet also places these women at risk of organ damage, including heart toxicity. Our pilot study suggests that asymptomatic declines in heart perfusion are observed over several months on this therapy. In this work we will study women with serial heart imaging to more fully understand the impact of this treatment on small and large heart vessels, as well as to study if there are patient characteristics, blood biomarkers or electrocardiogram changes which can predict who is at greatest risk for heart damage from near-complete estrogen deprivation.